Apolipoprotein CIII inhibition in partial lipodystrophy

In the past fiscal year, this study was IRB approved, and initiated recruitment. To date, one subject has been randomized and completed the placebo-controlled portion of the study and continued to the open-label portion of the study. Recruitment of additional subjects is ongoing.